Biostatistics and Bioinformatics Core

CORE 2 - PROJECT SUMMARY – BIOSTATISTICS AND BIOINFORMATICS CORE
The principal objective of the Biostatistics and Bioinformatics Core (CORE 2) is to provide P01 project
investigators a centralized resource for biostatistics and bioinformatics expertise and support. The Core 2
assembles a team of quantitative scientists with a wide range of expertise and a documented record of
collaboration with project leaders to address statistical issues and bioinformatics analysis at all levels of
investigation. This Core will support investigators from the design of laboratory experiments and translational
studies to the maintenance of data quality; and from conclusions based formal hypothesis testing to important
discovery with systematic data exploration. Primary functions of the Core include: developing study designs and
formal hypothesis testing strategies; supporting data collection; developing mechanisms for the acquisition,
processing, and storage of high-quality data; and developing and implementing rigorous statistical and
bioinformatics analysis plans; facilitating data sharing. Core 2 will offer many benefits to the Overall Program by
providing efficient and consistent support to the projects and cores, and a diversity of expertise to contribute to
design and analysis issues. Core 2 members will interact frequently with project leaders and evaluate the
projects to ensure that all components contribute to the overall goals of the Program, and provide each project
with state-of-the-art experimental design and data analysis. The Specific Aims of Core 2 are: (1) To collaborate
with project investigators on the formulation of unambiguous hypotheses and hypothesis testing strategies, and
on designing experiments. (2) To provide support for all projects with data analysis including both formal
hypothesis tests and exploratory analyses as well as statistical modeling and sensitivity analyses of complex
data. (3) To provide data management, quality control, processing and integration that ensure consistency and
transparency of data analysis across projects and cores, and to facilitate data sharing; and (4) To develop new
statistical and bioinformatics methodologies to directly address complex data or design problems that arise in
projects and where current methods do not apply.